Administrative Core

Administrative Core - Abstract
The Penn Virome Characterization Center Program (VCC) consists of a highly interactive team of experienced
investigators who are seeking to take advantage of diverse longitudinal cohorts to study the human virome in
healthy individuals. The Administrative Core will provide the necessary organizational and administrative
structure as well as scientific oversight to support our integrated studies of the healthy human virome. Our
Program brings together a group of experienced investigators on the shared campus of the University of
Pennsylvania and Children’s Hospital of Philadelphia with complementary expertise and a history of productive
collaborations, and leverages a set of existing cohorts and biobank repositories ideally designed to advance the
goals of the HVP. The Administrative Core is co-led by the Penn VCC program directors Drs. Ronald Collman
and Frederic Bushman, who have a long track record of successful joint program leadership as well as
management of complex initiatives. Their primary objectives will be to provide scientific leadership, together with
the Penn VCC Executive Committee, monitor the scientific progress of the program, oversee distribution of
resources, stimulate project interactions, promote data integration, integrate the Penn VCC with the larger HVP
program, and ensure compliance with all regulatory and NIH guidelines. To accomplish this goal the
Administrative Core will:
Aim 1. Provide scientific and operational leadership to each element of the Penn VCC to maximize
scientific progress and optimize efficiency. The core will oversee productivity within each project, including
monitoring achievement of milestones.
Aim 2. Coordinate within the Penn VCC to ensure effective interactions between our cores and
collaborators. The Core will coordinate communication among all team members via in-person and electronic
forums. It will organize interactions with our Advisory Board. It will organize regular meetings to accommodate
both in-person and virtual attendance, for each Project and Core, and the full Program Team.
Aim 3. Coordinate interactions between the Penn VCC, NIH, and other VCCs within the HVP. The
Administrative Core will also organize interactions with NIH and other VCCs, and assist investigators in
maintaining project-specific federal and institutional regulatory compliance. The core will further oversee the
Penn VCC diversity initiative, and the evaluation and distribution of Pilot Grants in years 3-5.